Regulation of tumor-infiltrating T cells by macrophages

Project Abstract
Tumor-associated macrophages (TAMs), a major component of the tumor stromal mass, demonstrate great
phenotypic heterogeneity and diverse functional capabilities under the influence of local tumor
microenvironment (TME). These TAMs generally display an anti-inflammatory, M2-type phenotype and can
facilitate tumor growth by promoting angiogenesis, invasion and metastasis, as well as immune evasion.
However, it remains largely undefined exactly how these TAMs regulate anti-tumor immune responses within
the TME. The objective of this application is to understand the role of TAM-derived PD-L1/siglec-15 in inducing
intratumoral CD8 T cell dysfunction, to delineate mechanisms underlying PD-L1/siglec-15 upregulation in
TAMs as well as to develop novel strategies to promote intratumoral CD8 T cell infiltration and function in favor
of enhancing anti-tumor immunity. The long-term objective of this project is to understand signals required for
functional polarization of TAMs within the TME, and its contributions to immune cell dysregulations, cancer
development and progression, which may lead to the development of novel cancer therapeutic strategies.

Public health relevance
Project Narrative Tumor-associated macrophages play an important role in promoting tumor growth, angiogenesis, metastasis and immune evasion. However, how tumor-associated macrophages regulate anti-tumor immunity within the tumor microenvironment remains largely unknown. The proposed work will study the role of tumor-associated macrophages in inducing intraturmoral T cell dysfunction and develop novel strategies targeting tumor- associated macrophages for treating cancer.